Diversity Supplement to Role of Testosterone Induction of Hydrogen Sulfide in Erectile Dysfunction

R03 Project Summary/Abstract
Testosterone insufficiency is an adverse health condition that affects an increasing number of men. It
may be caused by prostate cancer treatment, but also by conditions associated with poor cardiometabolic
health such as obesity, diabetes, and hypertension. Erectile dysfunction (ED) is a common symptom in men
with testosterone insufficiency. The proposed research seeks to identify why testosterone has a protective
effect on the erectile system. Specifically, the possibility that testosterone activates cystathionine γ-lyase (CSE)
will be investigated. CSE is the primary enzyme that produces hydrogen sulfide in the vasculature. Hydrogen
sulfide is an important cellular signaling molecule that is known to have antioxidant, anti-inflammatory, and
vasodilatory properties. The vasodilatory effects of testosterone will be investigated in genetically modified
mice lacking the CSE gene, as well as their unmodified littermate controls. Tissue segments from these
animals will also be incubated with varying concentrations of testosterone, after which hydrogen sulfide
production capacity will be measured. Tissue segments from the corpus cavernosum and the arteries
responsible for supplying blood to the penis will be used for these studies, which include the internal iliac artery
and proximal and distal segments of the internal pudendal artery.
Previous studies indicate that chronic oxidative stress is a causative factor in ED pathogenesis in
response to testosterone insufficiency. One mechanism by which hydrogen sulfide exerts cellular signaling is
through binding to protein thiol groups, termed sulfhydration. It is hypothesized that hydrogen sulfide acts in
such a manner to promote the nuclear related factor 2 (Nrf2) translocation to the nucleus. Nrf2 is an important
transcription factor that regulates transcription of many cytoprotective and antioxidant genes. The ability of
hydrogen sulfide to induce antioxidant defense and alleviate erectile dysfunction in a mouse model of
testosterone insufficiency will be investigated. Male mice will receive a sham or castration surgery, after which
castrated mice will remain untreated, or receive a low-dose or a high-dose of an orally active, slow-releasing
hydrogen sulfide donor. Following the intervention, erectile function will be assessed by measuring
intracavernous pressure changes in response to electrical stimulation of the cavernous nerve. Neurovascular,
endothelial, and smooth muscle function will be assessed in the corpus cavernosum, internal iliac artery, and
distal and proximal segments of the internal pudendal artery using an ex vivo myograph system. Expression of
cytoprotective and antioxidant genes regulated by Nrf2 will be assessed in these tissues by quantitative RT-
PCR. Cytosolic and nuclear content of Nrf2 in these tissues will be measured by cellular fractionation and
Western blot. The penile redox state will be examined by measuring in vivo reactive oxygen species using a
microdialysis technique.

Public health relevance
Project Narrative This diversity supplement to R03DK131242 will support a post-masters fellowship for Mr. Clifford Pierre to conduct research in relation to the parent grant focusing on hypogonadism and erectile dysfunction. The supplemental activities provide scientific research training and professional and career development opportunities designed to foster Mr. Pierre’s career aspirations to become a clinician-scientist in the field of urology.